Translational Science Initiative

Abstract
A major strength of the Translational Science Initiative (TSI) is conducting a collaborative study to establish and
to validate NHP models for translational research, further improving the CPRC. The proposed project will
enhance the knowledge generated in the current funding cycle. During the next funding period we will implement
the project entitled “Comparative dynamics of the reproductive microbiome in SPF and conventional rhesus
macaques through multi-omic approaches”. The microbiome shapes dynamic biological systems coordinated in
full scale environments including eukaryotic hosts and are vital for animal's health. The microbiota comprises
all the microorganisms in each body niche including Prokaryotes (Bacteria, Archaea), Eukaryotes (e.g., Protozoa
or Fungi) as well as their microbial metabolites and responses that affect the host. The increase in non-
communicable and chronic diseases in humans has been linked to urbanization and a reduction in sociability.
Changes in diet, use of antibiotics, and exposure to environmental microbes are proposed to impact human
health via the gut microbiome. We expect that changes in the microbiota among SPF and conventional macaques
occur since birth, and that future management practices altering the newborn microbiome, could help in the
development of stronger and resilient microbiome in these animals used in biomedical research. We aim to
implement this project as the applied research component for our P40 application, to add value to the resource
by creating, expanding and to advance new scientific knowledge with a translational potential. Also we propose
the continuation of the Immunology Core as a complement research support to the proposed research project
and to in-house and external scientists using the Resources funded by other NIH projects.

Public health relevance
Narrative The goal of the Applied Research Component (ARC) proposed here is continues with the successful Translational Science Initiative (TSI) at the CPRC. The close evolutionary relationship between humans and nonhuman primates (NHPs) is reflected by many common features in their genetics, physiology, and biochemistry, and these similarities make NHPs especially valuable as model systems for biomedical research. During the execution of this project we will characterize the vaginal microbiome in non-pregnant primates and will assess their association with the multiple-body microbiome dynamics in gestation and postpartum in rhesus macaques. This will contribute to understand maternal-infant transmissibility and compare changes associated to SPF and conventional animals. As captivity is thought to significantly alter the overall microbial community composition leaving additional bio exclusion, social interactions, environmental exposure as well as exposure to human's other important factors modulating the animal microbiome and its health.